Socioeconomic Determinants of Health and Well-Being in a Low Resource Setting: A Case of Older Adults Living in a Rural Setting in the Northwestern Cambodia

PROJECT SUMMARY / ABSTRACT
BACKGROUND: Socioeconomic differentials and their influence on health of older adults is
disproportionately documented in high-income countries. Given socioeconomic, cultural and historical
differences between these countries and low- and middle-income countries (LMICs), findings could be biased
or even invalid for a universal generalization. Thus, aging studies on socioeconomic characteristics and health
must be examined contextually. Among older adults, such investigations are rare and just published in the last
twenty years. The hypothesis central to the socioeconomic status-health association is the negative
relationship between socioeconomic characteristics and health outcomes, but the extent to which this
association exists within a low-resource setting is not known among older adults of LMICs in Southeast Asia,
particularly Cambodia. Considering individual nations' cultural and historical differences may impact how
socioeconomic characteristics are conceptualized and measured, a precise examination of the topic is
required. From the life course perspective, the older population with histories of violence and psychological
distress must be studied within their cultural and historical context. Using survey data collected by this
investigator in 2019, this study proposes to examine physical and psychological health of older Cambodians
residing in a rural and low-resource setting in the northwestern Cambodia, using contextually sensitive
measures and a rigorous theoretical framework. AIMS: This project aims 1) to characterize older Cambodians
in terms of demographic characteristics, social support, socioeconomic characteristics, and physical and
psychological health, 2) to examine associations of socioeconomic characteristics with physical health and
psychological health among older Cambodians, and 3) to investigate potential mediating roles of social support
and welfare support in the associations. METHODS: This study will use the most recent aging data of 220
older adults living in a rural setting of three Cambodian provinces. Dependent variables include the number of
health complaints and psychological well-being index. Independent variables are household wealth index and a
latent variable derived from three subjective self-perceived economic circumstances. Social support and
welfare support are operationalized using Social Support and Social Network scale and status of welfare
assistance, respectively. Descriptive analysis will be used to achieve Aim 1. Structural equation modeling will
be used to examined Aim 2 and Aim 3. IMPLICATION: Findings will reduce disparity in social aging research
in LMICs and have practical significance for development of programs and policies targeting older adults living
in rural and low-resource settings. This investigation will further our understanding of the contextual
socioeconomic characteristics and social support that may be modifiable to influence health for older adults in
low-resource communities. This project is in direct response to Objective F-3 of the NIA 2020-2025 Strategic
Direction to develop and implement strategies to increase inclusion of underrepresented populations in aging
research.
1

Public health relevance
PROJECT NARRATIVE This study is relevant to public health because it addresses the limited knowledge about the roles of support system and the contextually specific socioeconomic influence on physical and psychological health of older adults in a low resource setting of rural Cambodia. Findings can be used by health interventionists and researchers to compare public health interventions focused on providing tangible resources against ones focused on improving self-image and the sense of economic fulfillment. Because this study will add to the small body of aging and public health literature about older Cambodians, the long-term goal is for aging researchers to use the findings to advance conceptual and empirical work in this country and other low- and middle-income countries, thus advancing the mission of the NIA to support social and economic research on aging around the world and to increase diversity in research among underrepresented population. 1